Administrative Core

Project Summary: Administrative Core
The leadership of the Vanderbilt Pre-Cancer Atlas (PCA) Center builds on an existing multidisciplinary team
that has been working together for over 15 years on the Vanderbilt GI Special Programs of Research
Excellence (SPORE). We have also recruited additional team members from Johns Hopkins to round out
expertise for the atlas construction. Each team member also has extensive experience in collaborative
research efforts across multiple studies and multiple institutions. The Administrative Core will provide the
primary scientific oversight for the Vanderbilt PCA activities. It will have primary management and oversight
responsibility for all Pre-Cancer Atlas (PCA) activities, which include reviewing and regulating financial
expenditures, creating and preparing necessary reports, internal and external communications, research
coordination, and ensuring compliance with all federal regulations and reporting requirements (including NIH
public access policy). Thus, the core directly supports all members and organizational components of the PCA.
The Administrative Core will coordinate collaborations with NCI and the HTAN. Our team has extensive
experience working within NCI-funded networks. As the funded HTAN centers are developed, there will be
multiple opportunities to find shared aims and potential new collaborative projects in which the Vanderbilt PCA
will enthusiastically participate and even lead. The Administrative Core will also ensure full compliance with the
data and resource sharing plans agreed upon with NCI and the HTAN. This will be accomplished by working
closely with the Data Analysis Unit to ensure that all relevant data and tools are transferred securely and in a
timely manner to the DCC. During the initial development of HTAN, the Unit Co-Leads will work closely with
DCC and HTAN centers in the development of SOPs and CDEs and metadata dictionaries to be collected
within the Vanderbilt PCA Adenoma Center and across the network. Based on our past experience and
present shared vision, we are fully committed to the success of the PCA Center and the common success of
the HTAN.